The role of astrogliosis in aging and the pathological and clinical progression of Alzheimer's Disease

Overall Summary/Abstract
Our research focuses on understanding the pathophysiological mechanisms that lead individuals to develop
dementia, especially Alzheimer’s disease (AD). Our findings, as well as those from others, indicate that there is
a complex interaction of clinical and subclinical cerebral and systemic factors during the pre-clinical phases of
AD, some which convey vulnerability and some which convey resilience. The use of state-of-the-art technology
is gradually providing us with better knowledge of the sequence of events and the role played by each risk
factor. There is agreement among researchers that inflammation plays a critical role in the AD
pathophysiological process, as noted in multiple pathological studies but examining inflammation in vivo has
been challenging. To address these issues, we propose to characterize a new PET tracer, SMBT-1, that has
high binding affinity for MAO-B, a proxy of astrogliosis. Astrogliosis is involved in Aβ deposition and alterations
in cerebral blood flow and blood brain barrier integrity. One critical remaining question is the temporal
relationship of astrogliosis to amyloid deposition, is astrogliosis reactive to Aβ deposition or does astrogliosis
represent an additional “hit” exacerbating the effects of amyloid and tau pathology. The present PPG proposes
to explore across 4 projects, the relationship of astrogliosis to AD pathology and risk factors using a
combination of state-of-the-art neuroimaging, clinical, blood biomarker (and neuropathological tools. We
propose to assemble a cohort of 300 participants age 55 and older who will complete annual
neuropsychological, clinical, and blood examinations on all participants. At 24 and 48 months follow up
evaluation will also include repeat PET and MRI scans to identify abnormalities and/or changes in Aβ and tau
deposition, astrogliosis, brain structure and function to determine severity and progression of AD pathology,
astrogliosis and cerebrovascular disease (CVD). Utilizing this cohort, Project 1 will focus on the hypothesis
that astrogliosis augments, either directly or independently, the effects of Aβ and tau pathology as well as the
effects of CVD on neurodegeneration (MRI) and cognition. In Project 2, we will explore the hypothesis that
astrogliosis mediates the association between health risk factors (cardiovascular risk factors and sleep) and
amyloid and tau pathology. Project-3 will utilize novel 7T MRI to assess the role of brain fluid dynamics in the
pathway between astrogliosis and AD pathology. Finally, Project 4 will use the existing ADRC and PPG
banked brains to characterize regional differences in SMBT-1 autoradiography and in vitro binding in relation to
fine-grained immunohistochemical and biochemical analyses of MAO-B/GFAP astrogliosis, amyloid and tau
pathology, vascular pathology, and synaptic markers in AD and non-AD autopsy brains, and it will ultimately
characterize SMBT-1 PET in relation to neuropathology in postmortem brains from PPG participants who come
to autopsy.

Public health relevance
Overall Narrative/Summary Our research focuses on understanding the mechanisms that lead individuals to develop Alzheimer’s disease (AD). There is agreement among researchers that astrogliosis, a form of inflammation) plays a critical role in the mechanism of AD but measurement in the living brain has been challenging. The present PPG proposes to explore the relationship of astrogliosis to AD pathology and AD risk factors using a combination of state-of-the- art neuroimaging, clinical, blood biomarker (and neuropathological tools.